KSHV Manipulates Host Iron Metabolism and Ferroptotic Cell Death Pathways, Creating Novel Vulnerability Points for Therapeutic Intervention.

PROJECT SUMMARY
Kaposi sarcoma (KS) is a multifocal angioproliferative tumor affecting the skin, oral mucosa, lymph nodes and
visceral organs. Common factors for KS development include infection with the oncogenic herpesvirus Kaposi
sarcoma herpesvirus (KSHV/HHV8) and immune deregulation. While ART has reduced KS incidence in the
Western world, it remains the most common AIDS-associated malignancy worldwide. Growing knowledge of KS
has improved treatment options, but it remains an incurable cancer causing significant morbidity and mortality,
particularly in resource-limited regions. Thus, there is an urgent need for effective and affordable novel therapies
for use in combination with, or instead of, conventional therapies. KSHV profoundly alters the transcriptome of
the host cell, significantly influencing the function of multiple cellular homeostatic and adaptive pathways.
Interrogation of these pathways has identified a number of components as potential therapeutic targets for KS,
but significant gaps in our knowledge of the virus-host interaction hamper progress. In this application, we focus
specifically on two important and inter-connected host cell pathways that are influenced by KSHV infection, iron
metabolism and the antioxidant pathway, and investigate why KSHV-infected EC are resistant to ferroptosis, an
iron-dependent form of regulated cell death that is characterized by accumulation of ROS and lethal oxidative
damage to phospholipids. To support abnormal growth, tumor cells typically have a higher iron need, which is
satisfied through altered expression of genes regulating iron uptake, utilization and storage. Our preliminary data
suggest that KS resembles other cancers in this regard and directly implicate KSHV in this phenotype. Notably,
in vitro infection of lymphatic endothelial cells (LEC) results in deregulation of iron metabolism genes and
development of an iron-responsive growth phenotype. While iron fuels tumor growth, iron addiction presents a
paradox: how to maintain redox homeostasis and resist ferroptotic death? Many tumor cells achieve this balance
with an enhanced antioxidant response that includes activation of ferroptosis suppressor pathways to resist lethal
lipid peroxidation. Our data show that KSHV upregulates SLC7A11 (xCT), a critical initiator of the canonical
xCT/GSH/GPX4 ferroptosis suppressor pathway, and that KSHV-infected cells are uniquely susceptible to
ferroptotic death when xCT is inhibited. In addition, KSHV upregulates the newly-identified anti-ferroptotic gene,
ferroptosis suppressor protein 1 (FSP1), which functions through an independent, CoQ-dependent, pathway to
suppress ferroptosis, thus presenting an alternate target for the selective elimination of KSHV-infected cells. In
this application, we will test the innovative premise that KSHV reprograms host cell metabolism both to acquire
iron for growth and to activate two independent but complementary ferroptosis suppressor pathways. We
hypothesize that this reprogramming, while important for tumor growth and survival, creates unique points of
vulnerability that can be therapeutically exploited.

Public health relevance
PROJECT NARRATIVE KSHV, the viral agent of Kaposi sarcoma (KS), alters expression of cellular genes involved in iron metabolism in order to acquire iron for growth while resisting an iron-dependent form of cell death known as ferroptosis. Iron addiction coupled with ferroptosis resistance is a feature of several tumors and activation of ferroptosis is considered a promising therapeutic strategy, but the relationship between iron and ferroptosis in KS has not yet been characterized or explored as a treatment option. Our goal is to address this deficit by (i) defining the importance of iron in KSHV pathogenesis, (ii) understanding how KSHV-infected cells resist ferroptotic death and (iii) evaluating the therapeutic potential of ferroptosis activation in an in vivo KS tumor model.